Betacoronaviruses: activation and antagonism of host innate immune responses

Human betacoronaviruses induce a wide spectrum of respiratory disease. MERS-CoV (MERS) and SARS-CoV-
2 (SARS-2), cause severe lethal pneumonia, while SARS-2 can also cause mild to asymptomatic disease in
some individuals. In contrast, infections with the “common” respiratory human beta-CoV OC43 are largely limited
to the upper respiratory tract. With only a few drugs that show promise against human CoVs, it remains
imperative to develop therapeutics for current and future emergent human CoVs. For this, we need to identify
and understand the host-virus interactions common to all or different among these viruses. A major focus of our
lab has been on the double-stranded (ds)RNA induced host responses to beta-CoVs: interferon production and
signaling; oligoadenylate synthetase-ribonuclease L and protein kinase R (PKR), that are both antiviral and pro-
inflammatory. We have shown that the conserved CoV replicase encoded nsp15 endoribonuclease (Endo)U
reduces dsRNA accumulation and activation of all three pathways while subgenera specific accessory proteins
add to the antagonism. Merbeco (MERS-CoV) and embeco (OC43) viruses shut down these pathways
effectively; in contrast, the sarbecovirus, SARS-2, replicates in respiratory derived cells despite activation of all
three. Preliminary data suggest that downstream effects of RNase L on inflammation and cell death may be more
impactful during SARS-2 infection than the modest antiviral effects. PKR and PKR-like ER kinase (PERK), both
kinases of the integrated stress response, when activated, phosphorylate protein synthesis initiation factor eIF2a,
leading to protein synthesis attenuation, providing an important control point in infection. Activation of PERK also
initiates a pathways of the unfolded protein response (UPR) to ER stress, which produces antiviral effects and
inflammation. We found that MERS and OC43 infection suppress phosphorylation of eIF2a by preventing PKR
activation and through a PERK pathway feedback loop, dephosphorylating eIF2a. In contrast SARS-2 promotes
p-eIF2a through both PKR and PERK, but maintains viral protein synthesis. This may occur in part via the CoV
replicase nsp1 protein, which promotes selective attenuation of host, but not viral, protein synthesis. Our overall
hypothesis is that betacoronaviruses of each subgenus have evolved unique ways to interact with host
responses to optimize replication and spread and that these differences influence pathogenic outcomes.
We propose to determine: the role of the conserved CoV EndoU and subgenera specific accessory proteins in
antagonizing host innate response pathways; the impact of OAS-RNase L activation on viral replication,
inflammation and cell death; and the effects of host PKR/PERK and viral nsp1 on control of protein synthesis
and virus replication. Our overall goal is to understand the similarities and differences in host interactions among
beta-CoVs of three subgenera. Our findings may identify novel therapeutic interventions targeting host or viral
proteins and indicate whether they may work as pan-CoV therapies or be unique to each beta-CoV subgenus,
and thus help prepare for future CoV outbreaks.

Public health relevance
SARS-CoV-2, MERS-CoV and HCoV-OC43 represent three different betacoronavirus subgenera and cause a wide spectrum of disease from asymptomatic to upper respiratory to lethal pneumonia. The proposed study of betacoronavirus interactions with double-stranded RNA induced antiviral pathways and the PKR-like ER kinase (PERK) pathway will reveal a more comprehensive picture of virus-host interactions and how they are similar or different among the betacoronaviruses from different subgenera. This information will aid in developing antiviral strategies to target both host pathways and viral proteins, to combat current coronaviruses and to prepare for future coronavirus spillovers into humans.